Circulating cell free tumor DNA (ctDNA) in patients with immune checkpoint inhibitor associated inflammatory arthritis (ICI-IA): developing a biomarker to assess immunosuppressive drug safety

PROJECT SUMMARY
Immune checkpoint inhibitors (ICI) are monoclonal antibodies that block regulators of T cell activation,
activating anti-cancer immunity and greatly improving overall survival in patients with advanced cancer.
However, ICI commonly cause immune related adverse events (irAE), including inflammatory arthritis (ICI-IA).
It is estimated that as many as 14,000 ICI-treated patients will develop ICI-IA each year. ICI-IA can i. be
destructive to the joint, ii. persist for months to years, and iii. require treatment with glucocorticoids and
immunosuppressive disease modifying antirheumatic drugs (DMARDs). However, immunosuppression may
worsen cancer survival in this setting. Identifying the safest approach to ICI-IA management (with regard to
tumor control) is a critical unmet need. However, cancer recurrence is measured on radiographic imaging
which is often performed months after ICI-IA treatment is initiated and this makes it difficult to disentangle
which medication or intervention may have been responsible. In this study, we use MRD-EDGE, a new ultra-
sensitive approach to measure circulating cell free tumor DNA (ctDNA) and identify patients with cancer
recurrence long before it is demonstrated on standard of care radiographic imaging. MRD-EDGE couples
whole genome sequencing with deep learning approaches to provide a tumor fraction detection sensitivity as
low as 10-5 and allow tracking of cancer ctDNA over time, even in patients with a low tumor burden. Even more
critically, this approach does not require reference to matched tumor tissue. This is important because
simultaneous tumor sampling is impractical in most clinical settings (e.g., rheumatology clinic). This study takes
advantage of plasma samples from patients enrolled in one of two large prospective ICI-IA registries, the
Hospital for Special Surgery rheumatic irAE Registry (2018-2022), and the multicenter Rheumatology Adverse
Events Due to Immunotherapy Observational Study (RADIOS) registry (first enrollment 1/2023). In Aim 1, we
measure ctDNA levels in patients with melanoma or non-small cell lung cancer (NSCLC) at their first visit for
ICI-IA to quantify the association between ctDNA and subsequent cancer progression. In Aim 2, we measure
changes in ctDNA from baseline to weeks 4, 8 and 12 after institution of glucocorticoids in ICI-IA patients, to
assess the sensitivity of this biomarker to the effects of immunosuppression, and the kinetics of change. Our
overarching hypothesis is that ctDNA can be detected in patients with ICI-IA long before cancer
progression is demonstrated on imaging, and that any rise in ctDNA will be detectable within 4 weeks
of initiating glucocorticoids. This study will provide preliminary data and optimal plasma sampling times for a
future interventional study (e.g., comparing up-front glucocorticoids to up-front IL6R inhibition for high-grade
irAE). If effect sizes are small, we will plan a much larger multicenter observational study powered to assess
ctDNA levels before and after steroid-sparing immunosuppressive agents including IL6 and TNF inhibitors.

Public health relevance
PROJECT NARRATIVE Immune checkpoint inhibitors (ICI) boost the immune system to combat cancer, but they can cause severe inflammatory arthritis (ICI-IA) requiring treatment with immunosuppressive medications, such as glucocorticoids. However, immunosuppression may hasten cancer recurrence. In this study we measure circulating cell free tumor DNA in the plasma of patients with ICI-IA using a novel and highly sensitive assay, to demonstrate that it can serve as a biomarker of cancer progression that is sensitive to the effects of immunosuppression, for use in a future interventional study.